DEcoding Emotional Dynamics Driving Mood Instability in Bipolar Disorder

Bipolar disorder (BD) is a serious mental health condition characterized by recurring episodes of mania,
hypomania, and depression. A defining feature of BD is mood instability, which contributes significantly to
emotional dysregulation, impaired functioning, and poor clinical outcomes. However, little is known about the
neural mechanisms underlying these emotional dynamics, in part due to the limitations of conventional
neuroimaging analyses, which average brain activity over time and fail to capture dynamic affective processes.
To address this gap, the proposed study leverages advances in functional neuroimaging and machine learning
to investigate how emotional states unfold and fluctuate over time in individuals with BD. Using a validated
task-based fMRI paradigm, the Think and Regulate Affective states Task (TReAT), we will decode emotional
states at each time point based on whole-brain activation patterns. We will also quantify brain state variability
using computational metrics from complexity science, such as metastability and fractal scaling, and identify
brain regions that drive emotional transitions using network control theory. Combining these approaches will
allow us to characterize emotional state variability over time and examine its underlying dynamics. This
approach is innovative in its use of moment-to-moment emotional state decoding, providing a high-resolution
view of emotional instability not possible with traditional neuroimaging analyses. Pilot data support the
feasibility of this method, showing that emotional states can be accurately decoded. Building on this
foundation, we will test the hypothesis that individuals with BD exhibit greater emotional lability, reduced
temporal coherence, and altered network controllability during emotional reflection. In addition to identifying
neural signatures of mood instability, the study will evaluate how emotion regulation strategies, particularly the
upregulation of positive affect, influence emotional trajectories in BD. This work has direct translational
potential: identifying the neural mechanisms of emotional instability will lay the groundwork for developing
personalized, brain-based interventions aimed at stabilizing mood. The long-term goal is to inform the design
of real-time, state-adaptive treatments that target the dynamic brain processes underlying emotional
dysregulation in BD.